Mechanisms of spatiotemporal signaling by GPCRs

Project Summary
G protein-coupled receptors (GPCRs) comprise the largest family of signaling receptors in animals, and as such,
they represent an important class of therapeutic targets. Following ligand binding and G protein activation at the
plasma membrane, GPCRs undergo regulated endocytosis and sorting for recycling or degradation. Traditionally,
studies of ligand-dependent GPCR signaling have focused on receptor-G protein coupling at the plasma
membrane (PM). However, it is now clear that GPCRs can continue to signal from internal membrane locations
and that the downstream responses elicited from intracellular signaling are distinct from those elicited from PM
signaling. While the biochemistry of GPCR activation has been studied in detail, the organization and regulation
of GPCR signaling in living cells remains an underexplored frontier. The proposed studies will investigate
fundamental mechanisms underpinning spatiotemporal regulation of GPCR signaling and will provide key
training to enable Dr. Blythe to become an independent leader in this emerging area of molecular and cellular
physiology. The mentored phase of this project will be carried out at the University of California, San Francisco
under the primary mentorship of Dr. Mark von Zastrow, a leader in the field of GPCR trafficking and signaling.
The long-term goals of this work are to understand (1) how the subcellular localization of GPCRs and their
associated proteins change in response to signaling and (2) how this cellular reorganization regulates their
distinct downstream responses. The first two Aims will focus on receptor trafficking and signaling, defining the
mechanisms by which unique endocytic (Aim 1) and recycling (Aim 2) pathways sculpt signaling by
endogenously expressed GPCRs in a HEK293 cell model. In carrying out these experiments, Dr. Blythe will gain
new experience in advanced imaging techniques, as well as in integral membrane protein biochemistry with the
help of Dr. Aashish Manglik (collaborator). Aim 3 frames the biology in a broader perspective by asking how the
dynamic subcellular localization of other proteins contributes to the spatiotemporal regulation of GPCR signaling.
Using a novel proximity labeling approach under the mentorship of Dr. Nevan Krogan (co-Mentor) and Dr. Ruth
Hüttenhain (collaborator), Dr. Blythe will map the changes in the proteomes of specific cellular compartments
during the activation of the same model GPCRs and explore how these changes dictate signaling. The proposed
work will enable a systems-level analysis of GPCR signaling that was not feasible with current approaches and
provide an invaluable training opportunity for Dr. Blythe in mass spectrometry-based proteomics. In summary,
this project will take advantage of the expertise of a diverse mentorship team and the world-class resources and
facilities at UCSF to tackle fundamental questions in GPCR biology.

Public health relevance
Project Narrative The proposed research will contribute fundamental insights into how signaling through G protein-coupled receptors (GPCRs) is organized and regulated in the cell. Because GPCRs control essentially every physiological process, this new knowledge will be informative for the design of therapeutics to treat a wide range of diseases.